Dissecting the impact of tumor-immune spatial interactions in mismatch-repair stratified colorectal cancers

PROJECT SUMMARY/ABSTRACT
Predicting tumor progression and response to therapy remains a challenge. In colorectal cancer (CRC),
immunotherapy has improved survival in a subset of patients, but has yet to make a significant impact on the
~85% of patients with mismatch-repair proficient (pMMR) tumors. However, there is emerging clinical evidence
that immunotherapy has activity in pMMR disease within the right clinical context. I hypothesize that there exists
an immunologically distinct subset of pMMR tumors with a unique tumor-immune microenvironment permissive
to T cell infiltration, which is not captured by genomics-based precision oncology approaches. In CRC tumors,
brisk T cell infiltration has been associated with improved disease-free survival and may indicate tumors primed
for immunotherapy response. However, it is not well understood how immune infiltration interplays with the
relative importance of somatic mutations, resident immune states, tumor architecture and clinical and
demographic factors. Newer spatial profiling technologies, including highly multiplexed immunofluorescence
(mIF) and spatial transcriptomics (ST), can discriminate immune subtypes and precisely quantify tumor-immune
organization that are not possible to discern through dissociative or bulk approaches. However, the translational
relevance of these spatial methods is limited by (i) small sample sizes, (ii) sparse clinical annotation, (iii) and a
lack of robust computational tools to integrate across spatial profiling modalities.
This proposal aims to advance our understanding of tumor-immune interactions in CRC through analysis
of multimodal spatial profiling data on a large cohort (>200) of primary CRC tumors. In Aim 1, I will
immunophenotype cells from highly multiplexed IF data and identify recurrent immune networks. I will leverage
my experience with non-parametric 2D models for somatic rearrangements to develop a null background model
for spatial data. I will then test the significance of immune-immune interactions and their association with T cell
infiltration and activation states, stratified by MMR status. In Aim 2, I will use H&E and mIF to test the hypothesis
that tumor architecture and tumor-cell intrinsic cell cycle and cohesion programs are significantly associated with
physical T cell exclusion. I will then perform gene discovery on the key immune networks and tumor regions
identified in Aims 1-2 using an external cohort of whole-slide ST data. In Aim 3, I will combine these insights with
an integrated analysis of genomic and clinical data to identify the principal determinants of T cell infiltration and
their relative effect on clinical outcomes. I will then extend these findings with an IF-trained deep learning model
to test the feasibility of H&E-only models for identifying T infiltration in a large collection of whole-slide H&E
images. I anticipate that the computational tools and biological insights developed through this proposal will
significantly advance our understanding of CRC biology and serve as a basis for my independent research career
in translational oncology and computational multimodal tissue profiling.

Public health relevance
PROJECT NARRATIVE Colorectal cancer is a leading cause of cancer-related deaths, and growing evidence suggests that more patients, including many with mismatch-repair proficient tumors (pMMR), may benefit from therapies that activate an immune response against tumor cells. This proposal will use new tissue imaging technologies and computational approaches, applied to a large collection of colorectal tumors, to better understand the spatial organization of these critical tumor-immune interactions and determine their relationship to tumor mutations and clinical outcomes. Successful completion of this project will advance our ability to match patients with the best therapies and identify new ways to target tumor-immune interactions.